Role of Smooth Muscle Calponin in Vascular Pathobiology

There is now incontrovertible evidence from sophisticated lineage tracing studies that vascular smooth muscle
cell (VSMC) de-differentiation contributes substantively to a number of vascular diseases. A major manifesta-
tion of such phenotypic change is attenuated expression of a battery of VSMC-restricted genes, including the
enigmatic smooth muscle calponin (Cnn1) gene. The function of Cnn1 has been studied primarily in vitro or in
a single knockout mouse wherein several exons and introns were replaced with a neo cassette which, as
detailed below, obfuscates accurate interpretation of phenotypes. We have championed the CRISPR-Cas9
genome editing system in mice to engineer subtle substitutions within regulatory elements of many genes,
leaving intact all coding sequences. We report here a remarkable phenotype wherein a single base change of
a single CArG box in the Cnn1 locus abolishes expression of CNN1 in vascular (but not visceral) SMC. Full
expression of CNN1 is restored with a BAC carrying human CNN1 or CRISPR-mediated activation of the en-
dogenous Cnn1 promoter. Cnn1 CArG mutant mice, representing the first animal models of regulatory element
edits, also show elevation in VSMC DNA synthesis and defective contractile competence. Conversely, over-
expression of BAC-CNN1 suppresses VSMC growth, antagonizes neointimal formation, reduces VSMC lipid
uptake, and enhances contractile gene expression. Interestingly, CNN1-Ser175 appears to be a critical residue
for some of these effects making it an attractive amino acid for CRISPR-mediated editing in mice. Additional
data support CNN1 as a scaffold for ERK signaling and effector of the immotile state of differentiated VSMC.
Importantly, a complete understanding of CNN1 function is complicated by robust expression of two related
genes (Cnn2 and Cnn3) in VSMC. We hypothesize that CNN1 functions in concert with other CNN isoforms to
maintain a mature VSMC differentiated state. This hypothesis will be tested in three aims using state-of-the-art
tools in genetics, animal models of disease, and molecular physiology assays of VSMC function. Aim 1 will
exploit the single base edit in Cnn1 as a novel loss-of-function mouse in context of acute and chronic vascular
disease models; complementation studies will be carried out in vitro and in vivo to rigorously ascribe pheno-
typic changes to the specific loss of CNN1. Aim 2 will exploit a well-characterized BAC mouse to elucidate
functions associated with Cnn1 gain-of-function in models of vascular disease used in Aim 1. Complementary
CRISPR editing of the BAC mouse, in background of Cnn1 KO, will afford exquisite insight into functional
residues that mediate CNN1 function. Aim 3 will exploit new floxed Cnn2 and Cnn3 mice with an exciting
VSMC-specific Cre driver we have developed to address, for the first time, triple Cnn KO mouse models at
baseline and in acute or chronic vascular disease models. These studies, based on paradigm-shifting
approaches to gene KOs, serve as a template for the study of other gene families linked to VSMC differen-
tiation and will inform future studies targeting CNN1 in diseases where VSMC differentiation is compromised.

Public health relevance
Diseases of blood vessels involve radical changes in the normal program of gene expression and function, the underlying nature of which is poorly understood. We have used the revolutionary CRISPR system of genome editing to study a gene called CNN1, which is specific for smooth muscle cells in blood vessels. We will study this gene, along with related genes, in both cells and blood vessels to gain new insights into vascular diseases.